The Role of Kidney Disease in Inhibiting the Regression of Atherosclerosis

DESCRIPTION (provided by applicant): The long-term objective of this training award is to acquire the skills and experience necessary to become an innovative, productive, and independent physician-scientist in the field of chronic kidney disease (CKD)-related atherosclerosis. CKD is a known accelerant of atherosclerosis. Indeed, cardiovascular disease is the leading cause of mortality in patients with CKD. After accounting for frequently comorbid conditions, such as diabetes and hypertension, renal disease emerges as an independent risk factor for cardiovascular disease. The CKD-specific mechanisms responsible have not bet fully elucidated. This proposal aims to advance the understanding of CKD-related atherosclerosis by examining the mechanisms by which renal disease may interfere with the regression of atherosclerosis. Atherosclerotic plaques are dynamic: the net result of progressive and regressive forces. Pilot data suggests that decreased renal function impairs regression of atherosclerosis. ApoE-/- mice are used to generate atherosclerotic aortic lesions. Aortae are then transplanted into wild-type mice with or without kidney disease (remnant kidney model) to investigate how renal impairment affects regression of the atherosclerotic lesions. The hypotheses to be tested are: 1) kidney disease prevents the regression of atherosclerosis 2) the impairment is a result of defective chemokine receptor 7 (CCR7) signaling. Experiments will utilize immunohistochemistry, ELISA, laser-capture microdissection, real-time PCR, microarray analysis and in vitro migration assays. Conventional therapy does not fully mitigate the excess cardiovascular risk afflicting the large and growing population of patients with CKD. Investigating novel pathomechanisms of renal disease, such as impaired atherosclerosis regression, is a desirable goal.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic kidney disease affects millions of Americans. Many of those affected will die prematurely from heart disease. Understanding how kidney disease can worsen heart disease is an important goal. PROJECT NARRATIVE Chronic kidney disease affects millions of Americans. Many of those affected will die prematurely from heart disease. Understanding how kidney disease can worsen heart disease is an important goal. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS The long-term objective of this training award is to acquire the skills and experience necessary to become an innovative and productive independent translational investigator in the field of CKD-related atherosclerosis. The research objective of this proposal is to better understand the pathogenesis of accelerated atherosclerosis in CKD. Atherosclerotic plaques are dynamic. They are the net result of progressive and regressive forces. We have found that moderately impaired renal function inhibits regression of atherosclerosis using a well described mouse transplant model of regression. We have also found an accumulation of macrophages in atherosclerotic plaques in animals with kidney disease. Prior studies have identified macrophage emigration to be a critical event in regression. Specifically, signaling through chemokine receptor 7 (CCR7) is a necessary step for this emigration to occur. The mechanisms by which kidney disease inhibits regression and/or CCR7 signaling are unknown and will be the focus of study in this proposal. Aim 1. Define the course of atherosclerosis regression in kidney disease. Our preliminary data suggest that kidney disease interferes with regression of atherosclerosis and plaque macrophage migration. We will expand on these initial observations by characterizing the course of atherosclerosis regression and plaque macrophage dynamics in a uremic environment. 1.A. Perform a time course study to assess whether atherosclerosis regression and lesion macrophage depletion is prevented or merely delayed in uremic animals. Hypothesis: Uremia completely prevents atherosclerosis regression concomitant with lesion macrophage accumulation. 1.B. Determine whether the macrophages that accumulate in plaques of uremic animals result from increased influx or decreased efflux. Hypothesis: Macrophage accumulation seen in lesions from uremic animals is from a failure of macrophage emigration. Aim 2. Determine if CCR7 or other signaling pathways that may control macrophage migration are aberrant in uremia. CCR7 signaling is critical for dendritic cell homing to secondary lymphoid organs. CCR7 signaling has also been shown to be necessary for plaque regression and macrophage emigration in non-uremic animals8. CCR7 signaling acts through MAP kinase activation as well as Ca++ influx to stimulate cellular migration9. We will investigate the effect of uremia on markers of CCR7 signaling using in vivo, in vitro, candidate-based and non-biased approaches: 2.A. Compare in vivo markers of CCR7 activation in uremic and control animals. Hypothesis: Tissue from uremic animals will show less CCR7 activation than non-uremic controls. 2.B.1. Compare in vitro markers of CCR7 activation under uremic and control conditions. Hypothesis: Uremic serum will impair CCR7 signaling in cultured dendritic cells and macrophages. 2.B.2. Determine the effect of uremic serum on CCR7-dependent migration in vitro. Hypothesis: Uremic serum will impair CCR7-dependent migration of cultured dendritic cells and macrophages. 2.C. Utilize microarray analysis as an unbiased approach to detect differences in signaling between uremic and control lesion macrophages. Hypothesis: Lesion macrophages from uremic and non-uremic animals will manifest differential gene expression patterns. 2.D. To assess whether uremia leads to the general impairment of CCR7 signaling, we will compare the ability of control and uremic dendritic cells to migrate to lymph nodes in vivo. Hypothesis: Dendritic cells in uremic animals will show impaired migratory ability compared to non- uremic control dendritic cells.